Detection of SARS-CoV-2 and characterization of SARS-CoV-2 S-gene in major companion and food animals

Project Summary: SARS-CoV-2 is a major human respiratory pathogen that can cause COVID-19, a
disease with symptoms similar to those caused by Influenza A (Flu A) and Influenza B (Flu B) viruses. A few
major SARS-CoV-2 variants of concern (VOC) have been identified and associated with increased
transmissibility in humans, including the UK variant B.1.1.7/Alpha, South Africa variant B.1.351/Beta,
Japan/Brazil variant P.1/Gamma, California variants B.1.427/B.1.429/Epsilon, and India variants
B.1.6.7.1/B.1.6.7.2/Delta (CDC, 2021a). SARS-CoV-2 has also been found in different animal species,
including dogs, cats, tigers, lions, minks, ferrets etc. Transmission among individuals within an animal species
has been reported (Halfmann et al, 2020; OIE, 2021), as well as limited reports of animal to human
transmission (Hedman et al., 2021), yet more extensive studies may be needed to draw a conclusion. Both Flu
A and Flu B are major human and animal respiratory pathogens, and cause symptoms sometimes difficult to
differentiate from COVID-19. This proposal has three main goals: 1) Develop and validate a multiplex real-time
PCR assay for detection of SARS-CoV-2, Flu A and Flu B viruses; 2) Screening animal respiratory samples
submitted to KSVDL from Months 7-30 (2 years) of the grant period; and 3) Sequencing the spike protein-
encoding gene (S-gene) of all SARS-CoV-2 positive samples to identify and characterize potential variants and
their relationship to human strains.
From 2018-2020, Kansas State Veterinary Diagnostic Laboratory (KSVDL) received an annual average of
11,065 animal respiratory samples, including an average of 69 feline, 491 canine, 123 equine, 1,070 swine and
9,296 bovine samples for each year. All feline and canine respiratory samples and selected samples from
other species received in Months 7-30 during the grant period will be tested by the multiplex SARS-CoV-2/Flu
A/Flu B assay developed in the study. S-gene sequencing of all SARS-CoV-2 positive samples will be
attempted with a procedure optimized in this study and results compared to major VOC strains. Full or near-full
S-gene sequences will be phylogenetically analyzed to further study the variation and genetic diversity of the
SARS-CoV-2 strains identified from animal species. Analysis will also reveal if strains identified within an
animal species have a closer genetic relationship than strains between species. The S-gene sequences of
animal- and human-derived strains will be compared to determine if animal strains have been observed in
humans. Main goals include: 1) Provide comprehensive SARS-CoV-2 positive rates, for a duration of two
years, from samples collected from dogs, cats, horses, cattle and pigs; 2) Identify potential SARS-CoV-2 VOC
strains from positive samples; 3) Phylogenetically analyze the S-gene from all sequenceable positive samples
(Ct ≤ 32) to determine genetic diversity; 4) Identify and phylogenetically analyze similarities and differences of
the S-gene of animal- and human-derived SARS-CoV-2 strains.

Public health relevance
Project Narrative A multiplex real-time PCR assay for detection of SARS-CoV-2, Flu A and Flu B viruses will be developed to screen respiratory samples of companion and food animals. The S-gene will be targeted for attempted sequencing of all SARS-CoV-2 positive samples. Obtained S-gene sequences will be analyzed together with selected human sequences, including VOC strains to better understand the potential public health implications of SARS-CoV-2 strains identified from animals.